Evolution of Retrotransposon Control Mechanisms

PROJECT SUMMARY/ABSTRACT
Evolution of Retrotransposon Control Mechanisms
Dysregulated expression of retrotransposons and other transposable elements (TEs) can lead to
increases in TE copy number, DNA damage and instability, or aberrant regulation of host genes, which in turn
can contribute to human disease. Conversely, TE activity is required for processes ranging from early
mammalian development and cell senescence to horizontal transposon transfer (HTT) between species. The
natural downregulation or absence of TE defense mechanisms such as RNA interference, DNA methylation, and
repressive chromatin provides opportunities for TE expression and mobility. The fact that TEs do not always
proliferate unchecked in such cases suggests new mechanisms of TE control remain to be discovered. The
Saccharomyces cerevisiae/Ty paradigm is an attractive model for discovering new types of retrotransposon
control. S. cerevisiae and its close relative S. paradoxus lack canonical TE control pathways but contain multiple
active yet restrained retrotransposon families (Ty1-Ty5). We will expand on our discovery of a self-encoded form
of copy number control (CNC) for the canonical Ty1 element (Ty1c) to determine if other Ty elements undergo
forms of CNC, systematically determine whether Ty family interactions influence mobility, define the origin of
Ty1c CNC, and understand the evolution and function of endogenized Ty sequences. In addition, we will develop
new experimental models to study the mechanisms and consequences of HTT between species. Our work will
combine rigorous experimental and computational approaches to provide insight into how novel mechanisms of
retrotransposon regulation function and evolve to limit TE mobility and HTT.

Public health relevance
PROJECT NARRATIVE Diverse host defense systems regulate retrotransposon activity that contribute to normal mammalian development and brain function which, when dysregulated, can influence several disease states, including neurodegenerative disorders. We will investigate how novel mechanisms of retrotransposon control evolve and function in the well-developed Saccharomyces model that naturally lacks major host defense systems using rigorous computational and experimental approaches. Our work will inform studies on retrotransposons and retroviruses in mammals, deepen our understanding of how retroelement genes are domesticated and repurposed, and establish broadly applicable experimental approaches to understand the mechanism of horizontal transposon transfer between species.